Chemical Modifications to Wobble Uridines in tRNA Regulate Responses to Stress

Abstract
Cells respond to environmental stresses by regulating gene expression. Recent studies have
demonstrated that stress promotes changes in the levels of enzyme-modified nucleosides found in the anticodon
of many tRNAs, to regulate the translation of stress-response transcripts with specific codon usage patterns. In
bacteria the wobble U34 residue of tRNA can be enzymatically modified by writers to generate thiolation,
geranylation or selenation products at position 2, as well as distinct modifications to position 5, to produce 12
different modified uridines, with many predicted to play key roles in translation and stress responses. The Mnm
cluster enzymes can catalyze the formation of these modified uridines and due to their uniqueness to bacteria
and the importance of corresponding wobble uridines in the stress response, we propose that they can be
exploited to develop technology to tag modified RNA. We have used chemical biology and structural studies to
demonstrate that 2-thiouridine (s2U), geranyl-2-thiouridine (ges2U) and seleno-2-thiouridine (se2U) have different
base pairing specificity. In addition, using codon analytics of all E. coli genes, we have identified codon-biased
transcripts that could be translationally regulated by s2U, ges2U and se2U modifications. We have also shown
that cells deficient in the wobble U modifying enzymes MnmE and MnmH are sensitive to killing by
chloramphenicol (CAM) and have perturbed translation. We hypothesize that s2U, ges2U and se2U modification
levels change in response to environmental stress, to regulate the translation of response proteins. In this
application, we will synthesize and characterize 9 wobble modifications linked to MnmE and MnmH. Further, we
propose to characterize stress-induced changes in Mnm linked tRNA modifications and determine if translation
elongation of codon specific transcripts is linked to one of the 12 uridine tRNA modifications. In addition, we will
develop MnmH-based molecular tools to tag and visualize thiolated tRNAs in yeast and human cells. The
proposed studies are significant, as they will define a new form of translational regulation in bacteria, generate
new reagents and technologies for tagging epitranscriptomic marks and will provide a unified understanding of
the 12 different wobble uridines in bacterial tRNA.

Public health relevance
Narrative Bacteria contain unique wobble uridine modifications and writer enzymes, and these epitranscriptomic systems have been linked to stress responses. In this application we will use chemical biology approaches to synthesize and characterize wobble uridine modifications and define the roles of these RNA modifications and their writers in gene regulation. We will also exploit the bacterial wobble uridine writer MnmH (SelU) by developing clickable ligands that will be used to identify RNA modifications in yeast and human cancer cells. Ultimately our studies will develop a unified understanding of the 12 different wobble uridines in bacterial tRNA and provide new tools for epitranscriptomic research.